Impact of immunosuppression variability on outcomes after liver transplantation

PROJECT SUMMARY
Over 95% of liver transplant (LT) recipients have only one opportunity to receive a new liver during their
lifetimes and long-term patient survival depends upon prolonged graft functioning. As a result of advances in
immunosuppression (IS), over 70% of recipients survive more than 5 years after LT, yet wide variability exists
in clinical outcomes at the center-level. Most late post-LT deaths are not directly due to liver failure, but reflect
the adverse consequences of prolonged IS therapy. Due to the lack of national recommendations to guide IS
after LT, its management differs across centers. Moreover, comparative efficacy and safety data for IS
regimens are only available from small trials and meta-analyses. Their interpretation and generalizability are
limited due to the following factors: 1) care is often provided in settings that do not reflect “real world” clinical
practice; 2) few IS regimens are compared, often at a single time point; 3) late or rare outcomes are missed,
and 4) publication bias is evident. Population-level research is therefore needed to evaluate comprehensively
the comparative effectiveness and safety of IS regimens for LT. Understanding center differences in IS
management will also identify suboptimal practices, and further encourage the development of standardized
guidelines. Since fewer than 10% of the observed variability in post-transplant outcomes can be explained by
pre-LT factors, we hypothesize that targeting differences in post-LT management, such as IS regimen
selection, has the potential to change practice and improve outcomes on a wider scale. Using a novel linkage
of transplant data from the United Network for Organ Sharing and Medicare claims, the primary aims of the
proposed research are the following: Aim 1 – to describe center variability in IS management in the US; Aim 2
– to evaluate the association between IS regimen and the risks of graft failure and mortality; and Aim 3 – to
determine the association between IS regimen and the risks of acute rejection, severe infection and de novo
cancer as potential mechanisms for the relationships identified in Aim 2. This proposal will also foster Dr.
Bittermann's career development into a fully independent NIH-funded clinical investigator with a scientific focus
in LT pharmacoepidemiology and practice variability, facilitated through a comprehensive mentorship plan.
This will be accomplished by: 1) additional coursework on advanced methodologies through the Center for
Clinical Epidemiology and Biostatistics (CCEB) at the University of Pennsylvania, 2) direct implementation of
these acquired techniques under the close supervision of a carefully selected team of faculty with extensive
expertise in pharmacoepidemiology, transplant hepatology, and outcomes research, as well as longstanding
experience with successfully mentoring prior grant recipients, 3) involvement in the Center for
Pharmacoepidemiology Research and Training in the CCEB, and 4) development and submission of future
grants during the latter part of the award period to further IS and related post-transplant management issues in
LT recipients.

Public health relevance
PROJECT NARRATIVE Long-term survival after liver transplantation is dependent upon balancing the efficacy of immunosuppression with its safety. However, immunosuppression regimen choice is not standardized in the US, as no consensus recommendations or evidence-based guidelines are available to guide liver transplant physicians. This novel proposal will evaluate among-center variability in immunosuppression practices after liver transplantation and the association between regimen choice and important post-transplant outcomes at a population-level.